Inhalation Therapy Platform for Coronavirus Infection Treatment

PROJECT SUMMARY/ABSTRACT
The newly emerged SARS-CoV-2 coronavirus has demonstrated the deadly threat of pulmonary pathogens in
an exposure-naïve world with no existing vaccines or therapeutics at the ready. The development of effective
vaccines has provided key prophylactic products, but therapeutics remain important due to slow and incomplete
world coverage, along with emergence of resistance variants. There is especially a need for polytherapy
platforms that can be deployed in formats amenable to global settings, and need for platforms that can be rapidly
developed against future pulmonary threats. This project aims to develop a versatile inhalable therapeutic
platform against COVID-19 disease and future coronaviruses. It is designed for nebulizer and distributable
inhalation devices to maximize drug activity in the lung. The polymeric prodrug platform has recently shown
strong potentiating activity against highly lethal and antimicrobial-resistant bacterial lung infections. These
“drugamer” therapeutics improve the activity of pulmonary drugs by targeting them to specific cell reservoirs in
the lung with high and extended dosing profiles. The inhalable platform could be used by infected patients before
hospitalization, to reduce administrations by patients in crowded hospitals, and contribute a key distributable
therapeutic and prophylactic modality that is needed to protect caregivers and disadvantaged populations. The
proposal is structured around 4 specific aims: (1) Develop remdesivir and baracitinib as first drugamer candidates
that exploit the lung macrophage as a reservoir to achieve extended dosing, as well as targeted designs against
lung epithelium viral reservoirs. Remdesivir and baracitinib prodrug monomers will be developed with
corresponding drugamer designs with mannose and peptide targeting ligands for the alveolar macrophage and
epithelial compartments, respectively; (2) Characterize and optimize the drugamer candidates by criteria of how
they load drugs into the lung macrophage and epithelial cells with extended dosing times. This will lead to better
understanding of how to optimize targeting strategies in the lung for future antiviral development. The
mechanisms will be studied by using quantitative LC-MS pharmacokinetics characterization and safety
characterization using lung inflammatory response assessments; (3) Assess and optimize drugamer activity
against SARS-CoV-2 using the hACE2 mouse model. Viral load and survival studies will be used to characterize
and develop optimized drugamer and drugamer combinations that could in the future be carried forward into
preclinical development. Compared to current formulation approaches, the drugamers exhibit higher drug
loading, the ability to co-formulate widely varying drugs for polytherapy, and individually tailorable drug PK
profiles that minimize burst release. The modularity of the platform, together with scaled and rapid manufacturing
response attributes, will allow diverse incorporation of other drugs as combinations. These favorable platform
attributes motivate this project to develop a new repertoire of current and future coronavirus therapeutic products.

Public health relevance
Project Narrative This project will develop new Covid-19 therapeutics for infected patients and to protect caregiver and susceptible populations. The therapeutics are designed for nebulizer and mass-distributable inhalation devices to respond rapidly against COVID-19 outbreaks and future coronavirus threats.